Texas A&M Center for Environmental Health Research (TiCER)

Community Engagement Core (CEC): ABSTRACT
The overarching theme of the Texas A&M Center for Environmental Health Research
(TiCER) is “Enhancing Public Health by Identifying, Understanding and Reducing Adverse
Environmental Health Risks.” The Community Engagement Core (CEC) will be the
primary conduit for bi-directional communication between Center members and
communities across Texas. The mission of the CEC is to facilitate communication of
community environmental health concerns to researchers, while at the same time
supporting translation and dissemination of environmental health research results. This
mission will be accomplished by addressing several key elements of bi-directional
engagement. First, the problem identification element will focus on engaging communities
to identify and prioritize environmental health concerns. Second, the development of
scalable tools will focus on the use of citizen science, community design, and digital tools
that can be used to scale-up successful research translation activities of the CEC to
communities beyond our initial partners. Third, the communication of findings and
exploration of communication as an intervention will focus on the dissemination of
scientific findings, as well as the potential for family-based communication, to be used as
an intervention to reduce exposure. The leaders of the CEC have an established track
record of collaborative, interdisciplinary, and community-engaged projects, including a
Superfund Research Program Community Engagement Core, and are well positioned to
transmit community priorities to Center members and facilitate the translation of Center
findings to protect the publics’ health.